BIOPHYSICAL PARASITOLOGY

This project is concerned with (a) the genetic diversity of Trypanosoma cruzi and its implications to the epidemiology, course and diagnosis of Chagas' disease, (b) the development of high resolution flow cytometry instrumentation for analyses of cell populations and, (c) the utilization of flow cytometry and low light level video microscopy for the analyses of infectious agents. Flow cytometry was used to analyze the population dynamics of T. cruzi clone mixtures. The relative numbers of each clone in the population changed rapidly and the results are in quantitative agreement with mathematical models of competitive population growth; no dynamic equilibrium was found. These data emphasize the importance of working with well-defined clones in the laboratory and stress the importance of rapid isolation of single clones from clinical specimens. A similar situation occurs in Dipetalogaster maximus except that clones can coexist for longer periods of time in the bug. Electrocardiographic analyses of inbred mice infected with T. cruzi clones demonstrate that several known aspects of chronic Chagas' disease can be mimiced with the model. Electron bean x-ray microchemical analyses of T. cruzi clones demonstrate marked inter-clonal differences in Fe, Zn, S, Mg, K, Ca and P.